Visualizing B Cell Infiltration and Aggregation Within the Tumor Microenvironment

Project Summary
Emerging clinical evidence shows that activated immune cells, especially B and T lymphocytes, enhance
the response to cancer immunotherapies but are often excluded from tumors. High endothelial venules (HEVs)
may facilitate immune cell entry and tertiary lymphoid structure (TLS) formation within tumors, as observed in
histological samples. Dr. Komatsu’s lab has developed an immunostimulatory treatment to induce HEV and TLS
formation in previously HEV/TLS-free tumors. The combination of lymphotoxin beta receptor (LTβR) and STING
agonists reduces tumor size and promotes robust anti-tumor immunity. This study uses transgenic mice with a
dorsal skin window chamber (DSWC) tumor model undergoing intravital microscopy (IVM) to visualize B cell
infiltration through HEVs and immunity development via TLS formation. Bulk sequencing and
immunofluorescence analysis suggest that HEVs are the main route for B cell recruitment into tumors; intravital
imaging shows B cells roll more slowly on the endothelium of HEVs, indicating HEVs facilitate B cell entry into
tumors. Transgenic mice with fluorescent red B cells and fluorescent green blood vessels in DSWCs will visualize
and analyze B cell recruitment, rolling speeds, transmigration through tumor-associated HEVs, and real-time
TLS formation in agonist-treated KPC tumors using repeated IVM. These results will demonstrate for the first
time that HEVs are critical gateways for B cell entry and TLS formation within tumors, providing foundational
insights for targeted immunotherapies to enhance anti-tumor immunity. TLS formation in tumors may require
continuous B cell recruitment via chemokine signaling. This study investigates whether TLS are sustained by
ongoing B cell recruitment from circulation or clonal expansion within the tumor. Adoptive transfer experiments
suggest that TLS recruit B cells from the circulation, evident by the upregulation of chemokine genes known for
B cell recruitment following LTβR/STING agonist combination therapy that induces TLS formation. Maintenance
may involve both initial B cell infiltration and subsequent clonal expansion, marked by germinal center gene
upregulation. The anticipated findings will reveal that continuous recruitment of naïve B cells is essential for TLS
maintenance, offering new insights into tumor immunity mechanisms and paving the way for novel therapeutic
strategies that exploit B cell recruitment and clonal expansion to improve cancer treatment outcomes. The role
of chemotaxis in B cell recruitment to TLS will be tested by inhibiting this process with pertussis toxin-treated
naïve B cells, determining whether LTβR/STING agonist combination therapy promotes clonal expansion of B
cell-comprised TLS and anti-tumor immunity development. Results are expected to show that continuous
recruitment of naïve B cells and clonal expansion are essential for TLS formation and maintenance, providing
insights for novel targeted cancer immunotherapies. This research will produce novel insights into immune cell
infiltration and aggregation into intratumoral TLS, demonstrating experimental models needed for continued
onco-immunology research.

Public health relevance
Project Narrative Emerging clinical evidence suggests that the infiltration of tumors by activated immune cells, particularly B lymphocytes, is crucial for the success of immune-based cancer therapies. This research aims to investigate the role of high endothelial venules in B cell recruitment and subsequent aggregation into tertiary lymphoid structures, where anti-tumor immunity may be developed through clonally expanding B cells; employing novel transgenic models and advanced imaging techniques to elucidate the dynamics of tumor immunity and the potential for future therapeutic applications. for future therapeutic applications.